The 12th Conference on Metal Toxicity and Carcinogenesis

Project Summary
“The 12th Conference on Metal Toxicity and Carcinogenesis” will be held in Stony Brook, NY, October 26-29,
2025. We propose to continue this biennial conference series that has evolved over the last 20 years to
become the premier conference in the field of metal toxicity and carcinogenesis. The meeting will be
sponsored by Stony Brook University. This interdisciplinary scientific conference is a workshop that brings
together a community of scientists in the area of metal toxicity and carcinogenicity from around the U.S. and
some from overseas. The objectives of the meeting are to coordinate, exchange, and disseminate information
and to explore metal-induced toxicity and carcinogenicity. The focus will be mechanisms of metal-induced
toxicity, strategies for intervention and prevention, and possible translation from basic studies into clinical or
public policy. The conference content will challenge and seek to shift current research paradigms, or employ
novel approaches or methods to fulfill its purpose. The conference will cover concepts, approaches or
methodologies, instrumentation, or interventions novel to the field of metal toxicity and carcinogenicity as well
as in a broad sense. The conference will also address a refinement, improvement, or new application of
theoretical concepts, approaches or methodologies, instrumentation, or interventions. The Conference will
stimulate interactions of scientists and collaborations and help move the field forward.

Public health relevance
NARRATIVE “The 12th Conference on Metal Toxicity and Carcinogenesis” will be held in Stony Brook, NY, October 26-29, 2025. The Conference is a workshop that brings together a community of scientists in the area of metal toxicity and carcinogenicity from around the U.S. and some from overseas. The goals of the meeting are to coordinate, exchange, and disseminate information and to explore metal-induced toxicity and carcinogenicity.